Implementation of emergency department screening to impact rising syphilis rates in vulnerable populations

PROJECT SUMMARY
Syphilis rates in the U.S. have been increasing steadily since 2001, with more than 130,000 new cases reported
in 2019. Left untreated, syphilis can lead to neurologic, psychiatric, cardiovascular, and other severe medical
consequences, in addition to stillbirth or devastating congenital defects in infants of infected mothers. Syphilis
disproportionately affects minority populations, in particular Black and Hispanic communities. Rates of congenital
syphilis are also rising rapidly, paralleling an increase in rates among young women. Detection of syphilis among
women of childbearing potential will be key to eliminating congenital syphilis. Current screening strategies rely
on identification of symptoms or risk factors in patients attending ambulatory care, but this may result in many
missed diagnoses, as syphilis can remain asymptomatic for years, patients may not perceive themselves as at
risk or report relevant risk factors, and the patients most vulnerable to syphilis may also be the least likely to
attend routine outpatient care. To address this issue, I created and pilot-tested an approach for universal syphilis
screening in the emergency department (ED), where many vulnerable patients preferentially seek medical care.
My long-term goal is to scale up this program and create a robust model that can eventually be scaled-out to
other urban EDs in Chicago and across the country, and to accomplish this I will need additional data and training
in implementation science. In this career development proposal, I will evaluate and improve my screening model
and prepare for expansion to additional sites using implementation science strategies, informed by the
Exploration, Preparation, Implementation, Sustainment (EPIS) model, a robust determinants framework in
implementation science. The Exploration phase will consist of an assessment of the readiness of key
stakeholders outside our institution to adopt a similar screening model. The Preparation phase will be developed
concurrently to include an evaluation of the contextual factors that have contributed to successes and failures of
the existing screening program, including specifically the costs associated with such programs. The
Implementation and Sustainment phases represent future directions as the model is improved and sustained
over time at our hospital and ultimately implemented at other institutions as part of future R01-level studies. The
knowledge developed as a result of this proposal will fill important gaps in how to implement successful, context-
specific ED screening programs with effective linkage to care plans, which may serve not only to increase syphilis
diagnosis and treatment, but also could be applied to screening for other diseases affecting the most vulnerable
populations. This K23 award will provide advanced training in implementation science, mixed methods research,
and healthcare economics that will build on my background in public health and epidemiology. I will bring my
research and clinical experience together with that of an experienced mentorship team to develop the skills
necessary to become an independent investigator and eventually a leader in ED screening methodology and
implementation science.

Public health relevance
PROJECT NARRATIVE This study aims to decrease the burden of syphilis on vulnerable populations through implementation of an emergency department screening program that can be deployed in high-risk communities. This will have a huge potential impact on public health by decreasing complications of syphilis, interrupting the cycle of disease transmission and decreasing congenital syphilis. This work addresses NIH priorities to utilize implementation science to evaluate evidence-based practices for dissemination and implementation in real-world settings, as well as NIAID goals to develop innovative strategies to end the global epidemic of sexually transmitted infections.